Maximizing Access to Research Careers at Louisiana State University

PROJECT SUMMARY
The proposed MARC Program at Louisiana State University (LSU) will ensure the training of underrepresented
(UR) minority, disabled or economically disadvantaged undergraduate (UG) students for research careers and
leadership positions in the biomedical or behavioral sciences. LSU has emerged as a national model for
advancing and promoting inclusion, equity, and diversity and improving the success rates of underrepresented
students. The design of our proposed MARC program is based on evidence-based practices, previous
experiences, particularly with the NIH/NIGMS-sponsored LSU IMSD program, which has supported 20 UG
students/year (2004-2019), and guidance from nationally renowned faculty. In fact, five faculty at LSU,
including the PI, Co-PI, and two of the Advisory Committee members, are recipients of Presidential Awards for
Excellence in Science, Mathematics and Engineering Mentoring (PAESMEM). The overall goal of the LSU
MARC program is to provide high impact research experiences, mentoring, and advance professional and
career development for students, enhance the pool of students from underrepresented groups who
successfully enroll and complete Ph.D. or M.D./Ph.D. degrees, and to further develop and sustain a long-term
mentoring community of scientists. Our vision is that this program will produce highly skilled, competitive,
motivated and productive young scientists who will fill a national need, and will expand LSU faculty mentoring,
inclusion, and community outreach activities. The LSU MARC program will provide valuable biomedical
research training and career and curriculum development for 4 cohorts consisting of 12 undergraduate
scholars each through their junior and senior years. The five-year project will directly impact 60 total students.
Program scholars will receive individual counseling and mentoring, research training, mentoring, and various
other career and personal development activities. The four guiding objectives of the LSU MARC program are:
(1) Provide high-impact biomedical research training opportunities to high achieving students from UR groups;
(2) Improve MARC scholars' competitiveness through holistic academic, research, and social development and
enrichment activities; (3) Prepare MARC scholars for research careers; and (4) Develop and sustain a
mentoring community for MARC participants. The LSU MARC program will provide a holistic, student-centered
spectrum of educational activities, training opportunities, professional experiences, and personal development,
with the aim to increase student matriculation and persistence into Ph.D. or M.D./Ph.D. programs. Our
proposed innovative strategies include expanded biomedical research opportunities at LSU laboratories and
local research intensive facilities, research skills course, impactful mentoring training for scholars and faculty,
summer research experiences, field trips/site visits, outreach activities, a Gulf Coast MARC Symposium and
publication of MARC outcomes and best practices. The proposed MARC program activities are expected to
have high impact at LSU and maximize the benefits for its scholars, faculty participants, and the community.

Public health relevance
PROJECT NARRATIVE The LSU MARC program addresses the shortage of trained underrepresented, disabled, and/or economically disadvantaged students in biomedical and behavioral research fields. To close the educational achievement gap and build pathways to generate a highly skilled and diverse biomedical workforce, the LSU MARC program provides holistic, student centered spectrum of educational activities, training opportunities, professional experiences, and personal development that will prepare underrepresented groups for undergraduate and doctoral biomedical degrees and for careers as leading biomedical researchers.